Complexity: Innovations in Promoting Health through Team Science

Project Summary/Abstract
Complex chronic conditions (CCCs) cause substantial morbidity and mortality worldwide and
disproportionately affect disadvantaged and low/middle income regions. Although many CCCs are preventable,
and patients currently benefit from ongoing improvements in disease diagnosis and treatment, CCC-associated
morbidity and mortality remains substantial. Due to the inherent complexity associated with the inter-related
predisposing factors that influence health outcomes, multi-faceted approaches are critical to identifying future
interventions that can prevent and manage CCCs, and minimize/manage the short and long-term sequelae of
treatment and the disease itself. Future discovery of innovative and impactful approaches to minimize CCC
burden depends on the skill and willingness of emerging researchers to engage in team science, which offers
enhanced opportunities for success compared to a single disciplinary approach. This T32 competitive renewal
application will prepare nurse scientists to leverage collaborative science teams and networks when
developing and testing interventions to improve health in the context of high complexity. This application builds
on the important concept of complexity by expanding the training opportunities in the area of team science.
Thus, the goal of this T32 renewal application, entitled Complexity: Innovations in Promoting Health
through Team Science (CHEeTAh), is to educate 11 pre-doctoral trainees to become innovative scientists who
will leverage team science approaches to promote health for individuals and populations with (or at risk for)
CCCs. The pedagogic program, research training, and mentorship plans outlined in this proposal are
consistent with our current successful T32 training program, but we will expand the previous three-year training
plan to a four-year plan to facilitate more training in team science.
Specifically, we will train nurse scientists to: 1) Investigate the complex array of personal, social, and
environmental factors that influence the health of individuals and populations at risk for or diagnosed with
chronic illness to inform the design and testing of interventions; 2) Integrate team science approaches when
developing and testing innovative interventions to address highly complex problems; 3) Design and test
innovative approaches to promote health which prevent the development of chronic conditions at the individual
and population levels in those at higher risk; and 4) Design and test innovative approaches to promote health
among those with chronic conditions to enable them to live well with chronic illness.
The training program is organized in four pillars: course work, research experience, mentoring, and
professional socialization, all inclusive of leading and participating in teams. Trainees will benefit from an
individualized development plan and an interdisciplinary mentorship team. Promoting team science is a cross-
cutting theme within the National Institute of Health (NIH) strategic plan and the National Institute of Nursing
Research (NINR) priority to foster cross-disciplinary research to advance symptom science.

Public health relevance
PROJECT NARRATIVE Complex chronic conditions account for a large portion of disease, death, and disability in the US. However, progress in finding effective solutions to these health problems are thwarted by the lack of nurses with skills to address these complex problems in the context of the team scientific processes that will be necessary. The proposed project will contribute to the health of the Nation by supplying nurse-scientists who are prepared to become innovative and successful scientists who will leverage team science approaches to promote health for individuals with or at risk for complex chronic conditions.